Somatic control of germline differentiation in spermatogenesis.

Project Summary
The broad, long-term objectives of this application are to characterize soma-germline interactions during
adult spermatogenesis. The proposal will utilize biochemistry, site-directed mutagenesis in cultured cells and
immunofluorescence, genetics, RNA interference, targeted protein degradation and rescue assays in the adult
Drosophila testis to determine how a secreted, conserved, immunoglobulin (Ig) domain protein maintains the
blood-testis barrier (BTB) in somatic support cells of adult testes. We will capitalize upon the powerful genetics
available in Drosophila, as well as the ability to unequivocally identify the niche, germline stem cells (GSCs),
spermatogonia and somatic support cells in the Drosophila testis. This proposal is supported by unpublished
results demonstrating that (1) the secreted protein is expressed in somatic cells of the testis and is required for
spermatogonial differentiation and for robust expression of a BTB domain protein; (2) the only known receptor
for the secreted protein is a neuronal adhesion protein that is not expressed or required in the adult testis,
indicating that another receptor is involved; (3) another receptor with high homology to known one is expressed
in somatic membranes in the adult testis and its depletion leads to phenotypes similar to loss of the secreted
protein; (4) this other receptor is required for maintenance of the blood-brain-barrier during development,
suggesting a conserved barrier function. Aim 1 centers on using in vitro assays (cell-cell aggregation, affinity
purification followed by mass spectrometry, structure-function analysis) to determine how the secreted ligand
and receptor interact in cultured cells and on employing in vivo assays (split-GFP reconstitution and deGradFP-
dependent protein degradation with genetic “add back”) to test whether these interactions occur in the adult
testis. The Aim 2 is focused on determining whether the permeability barrier function of the BTB is compromised
in testes lacking the ligand or receptor. These experiments are designed to reveal mechanistic insights into how
the BTB domain is maintained in adults. The studies in this proposal will increase the knowledge base about
signals that maintain spermatogenesis during adult stages and will foster new avenues of research into
mechanisms and treatments for age-related male infertility.

Public health relevance
Project Narrative Soma-germline interactions are required for spermatogenesis and for the production of offspring. The testis of the fruit fly Drosophila is an ideal model to study soma-germline interactions and spermatogenesis during adulthood. Our study is designed to assess how somatic cellular growth and somatic encapsulation of germ cells is maintained during adulthood and may open up new therapies for treating human age-related male infertility.